Molecular Biological Approaches to Endocrinology

Project Abstract
We are pleased to report that our Training Program has successfully trained graduate students who have
become the next generation of creative independent investigators in the fields of gene regulation,
mechanism of hormone and signal action, molecular genetics of development, homeostasis, metabolism and
disease, inflammation, learning and neuronal function, global genomics and contemporary bioinformatics.
This achievement reflects the strength of our training program fueled by its innovative, forward-thinking, and
distinguished core faculty, who reflect the rich research environment of the La Jolla Mesa area that includes
the UCSD School of Medicine, School of Biology, the Jacobs School of Engineering and the UCSD Program
in Bioinformatics and Systems Biology. Notably, it also includes the Salk Institute for Biological Studies, The
Scripps Research Institute, and the Sanford Burnham Prebys Medical Discovery Institute. Additionally, the
recently constituted UCSD Institute for Genomic Medicine has further strengthened training in the
contemporary fields of global genomics and chromatin biology. The core faculty are all internationally
recognized for their research accomplishments and have strong records of training graduate students who
have gone on to very productive academic and industry careers. Our program is highly interdisciplinary
involving faculty from various Schools and Programs as well as the Salk Institute and The Scripps Research
Institute. Graduate students are immersed in contemporary research approaches to important questions and
have the full range of training in contemporary global genomics techniques, biochemistry, molecular biology,
genetics, and gene regulation. Most importantly, students are expected to acquire a broad background of the
scientific literature, and critical thinking, as well as the creative spirit that underlies success in these research
areas. Formal coursework, hands-on bench experience, and intensive interaction and collaboration
opportunities with program faculty will also prepare trainees for pursuing independent academic careers in
these disciplines. We hope to be permitted the opportunity to continue this highly successful predoctoral
training grant with a request for expansion for two postdoctoral trainees. Six predoctoral trainees per year
are drawn from the highly competitive PhD programs. Candidates are chosen from more than 1000
applicants. Established criteria include research background, grade point average, GRE scores, and
interviews with faculty and senior graduate students. All programs have a full complement of Diversity
Initiatives. Trainees are directed towards careers in contemporary gene regulation, endocrinology,
epigenomics, informatics, chromatin biology, metabolism and neurobiology, with a perspective towards
translational application to human disease. Trainees are encouraged to develop skills in bench science,
critical thinking, grantsmanship, teaching, and translational research in order to become independent
investigators at leading academic institutions and make important contributions to biomedical science.

Public health relevance
Project Narrative The relevance of our training program, Molecular Biological Approaches to Endocrinology, to basic science research and translation to human disease in the United States has been remarkable, with our outstanding faculty having trained >60 independent investigators over the course of this program. These talented trainees have made a critical impact on our understanding of genetics, genomics, transcription, inflammation, neurodevelopment, development of the endocrine system, neurodegeneration, and a series of common and devastating diseases, including cancer, cardiovascular disease and neurodegeneration. More than 80% of our “graduates” have gone on to successful careers as independent investigators at our best Universities, have made sustained, transformative and high impact research contributions, as well as teaching future generations of American scientists.